Functional LnFe-NxHy Models of Biological N2 Fixation

Abstract Not applicable - Administrative Supplement for Equipment. Please refer to the Research Strategy.

Public health relevance
Project Narrative Not applicable - Administrative Supplement for Equipment